Mental and Respiratory Health Impacts of the Maui WUI Fire in Children and Adults

ABSTRACT
The wildland-urban interface (WUI) fire of August 8, 2023 in Maui has been the deadliest in US history. It
completely swallowed the historical town of Lahaina, claimed > 100 human lives, burned > 2000 structures, and
displaced thousands of people. The combustion of biomass, buildings, furniture, and automobiles generated a
complex mixture of toxic compounds including lead, arsenic, asbestos, cyanates, dioxins, and flame retardants.
These compounds are enriched in the ashes, residues, and soils in the burn site and surrounding areas. As of
January 2024, most of the burn site remained inaccessible to the public as residues/soils were deemed toxic.
Many of these toxic compounds are persistent in the environment, causing cumulative exposures years and
even decades after the fire. The over goal of this time-sensitive R21 project is to address fire victims’ current and
future health concerns. We formed an academia-government-community partnership to pursue the following
aims. Aim 1: To assess the impact of the fire on mental and respiratory health outcomes. We plan to enroll
child and adult participants from 100 fire-displaced households and 100 nonaffected households. Respiratory
symptoms, lung function, and mental health and wellness will be assessed using the NIEHS Disaster Research
Protocols (the RAPIDD toolkits) with modifications to clarify the specific disaster setting. We hypothesize that
individuals who experienced displacement would have worse mental and respiratory health outcomes than
individuals without displacement experience, adjusted by demographics, lifestyle, socioeconomics, pre-fire
environmental exposure history, and pre-fire health status. Aim 2: To assess the change in health outcomes
one year later, relative to baseline impact assessed in Aim 1. We hypothesize that individuals affected more
severely at baseline would have worse respiratory and mental health outcomes at follow-up compared to those
affected less severely. Aim 3: To collect house dust, wristband, and biological samples for future
investigations of longer-term health effects of cumulative and/or changing exposures resulting from the
disaster. These samples can be analyzed to capture important time windows of toxic exposure and biomarkers
indicative of toxicity and disease risk. They will be integrated in our planned R01 that aims to address lasting
concerns of the victims while studying the interactions between respiratory and mental health outcomes in toxic
exposure and disaster contexts. Overarching Aim: To report the study findings back timely to study
participants and the larger community. We will form a dissemination team with extensive experience in bi-
directional communications between researchers and the community. This team will answer participants’ and
community questions in a proper manner taking into considerations of culture sensitivity. The team will facilitate
receiving input from the community to help develop survey instruments and collect data and samples. The data
and samples will be an invaluable resource that can be shared with other researchers who wish to study WUI
fires that are becoming increasingly common.
1

Public health relevance
PROJECT NARRATIVE This time-sensitive project aims to assess the impact of the deadliest wildland-urban interface (WUI) fires in US history on mental and respiratory health in both child and adult victims. Assessments will be made at baseline and one year later with a goal to provide data, biospecimens and environmental samples for future investigation of long-term health effects and lasting community concerns.